Impact of Aiolos on intestinal intraepithelial lymphocytes

Project Summary/Abstract
Inflammatory bowel disease (IBD) is a common disorder that causes inflammation predominantly in the digestive
tract. Although treatment options have expanded in the past two decades, a significant portion of patients still
suffer from poor treatment response and chronic clinical courses. Various responses to currently available
therapy are in part due to the heterogeneity of pathogenesis, and novel mechanistic insight that could lead to
new therapeutic options is critically needed. Intestinal intraepithelial lymphocytes (IELs) are a heterogeneous
group of tissue-resident lymphocytes, and pathological activation of IELs is implicated in the exacerbation of IBD.
However, the regulatory mechanisms of IELs during activation are not well understood. Aiolos, a transcription
factor encoded by Ikzf3, is expressed exclusively in lymphocytes, and contributes to B cell activation and NK cell
maturation. Aiolos mutations are implicated in various autoimmune diseases including IBD, but the roles of Aiolos
in IELs or gut homeostasis have not been studied in the past. I discovered that Aiolos is highly expressed in IELs
and that Aiolos-deficient IELs are more activated and express higher levels of activation markers (NK receptors)
and cytokines (interferon-g and granzymes) compared to wild-type cells. These preliminary results indicate
that Aiolos strongly suppresses IEL activation. Since Aiolos is a transcription factor modulating chromatin
remodeling, I hypothesize that Aiolos binds to the enhancer regions of genes associated with IEL activation and
controls their expression by altering epigenetic modifications. Additionally, since Aiolos potently regulates IEL
activation, I hypothesize that Aiolos-deficient IELs modulate the host response to colitogenic infection and
intestinal inflammation. In this proposed project, I will address these hypotheses with the following aims: (Aim
1) to identify Aiolos binding sites and define the contribution of Aiolos to epigenetic landscape in IELs, and (Aim
2) to investigate the impact of Aiolos-deficient IELs during mucosal inflammation. In Aim 1, I will utilize state-of-
the-art epigenetic techniques to examine Aiolos binding sites in wild-type IELs and investigate how Aiolos
deficiency alters epigenetic modifications in IELs. I plan to examine differences of epigenetic modifications
between Aiolos-deficient IELs and wild-type IELs by comparing open chromatin regions and histone
modifications. In Aim 2, I will challenge mice with Aiolos-deficient IELs and mice with wild-type IELs with
Salmonella typhimurium and dextran sodium salt-induced colitis to delineate the impact of Aiolos-deficient IELs
on host responses to intestinal infection and inflammation. Taken together, this project will contribute to profiling
cis-regulatory circuits of IELs and could advance our understanding of the pathogenesis of IBD, which could
eventually lead to the identification of new therapeutic targets.

Public health relevance
Narrative Pathological activation of intestinal intraepithelial lymphocytes (IELs) is implicated in exacerbation of inflammatory bowel disease (IBD), but the mechanisms that suppresses IEL activation during intestinal inflammation remain unknown. I discovered the novel regulatory roles of Aiolos, a transcription factor encoded by Ikzf3, in IEL activation, and this project will investigate how Aiolos-deficient IELs modulate host responses to gut inflammation. This proposed project could advance our understanding of the pathogenesis of IBD and may eventually identify novel therapeutic targets.